Vaginal Microbiome, Inflammatory Mediators, Metabolome, and Dysmenorrhea Symptom-based Phenotypes

PROJECT SUMMARY
Dysmenorrhea is a prevalent pain condition and a risk factor for developing other chronic pain conditions.
Dysmenorrhea experiences vary significantly among individual women. Some women are symptom-free, and
those with symptoms fall into three dysmenorrhea symptom phenotypes: mild localized pain, severe localized
pain, and multiple severe symptoms. The mechanisms underlying this individual variation remain incompletely
understood, creating barriers for expanding and personalizing dysmenorrhea treatment options. Given the role
of the vaginal microbiota in inflammation and female reproductive health and the proof-of-concept data linking
vaginal microbiota and dysmenorrhea phenotypes, the study of vaginal microbiota and their function is a
promising avenue to understand individual differences in dysmenorrhea. Our central hypothesis is that vaginal
microbiota contributes to dysmenorrhea symptoms by modulating the host inflammatory response in the genital
tract. The purpose of this proposed, prospective, longitudinal study is to examine relationships among vaginal
microbiome, inflammatory mediators, sex hormones, metabolome, and dysmenorrhea phenotypes. Racially
diverse female participants (aged 14-39) will be recruited into four groups: three dysmenorrhea phenotype
groups and one symptom-free group. These individuals will provide vaginal samples off- and on-menses, blood
samples, and questionnaire data. The specific aims of the study are to (1) differentiate vaginal microbial taxa,
genes, and pathways associated with dysmenorrhea phenotypes using shotgun metagenomic and qPCR
methods; (2) differentiate inflammatory mediators and metabolites associated with dysmenorrhea phenotypes
using immunoassays of cytokines and mass spectrometry-based metabolomics; and (3) identify taxonomic
drivers of functional shifts in vaginal metabolome associated with severe dysmenorrhea symptoms. Network-
based systems biology and predictive modeling approaches will be used to integrate phenotypic, demographic,
behavioral, metagenomic, cytokine, metabolomic, and hormonal data. This multi-omics approach will provide
rich information on the function of vaginal microbiota and metabolites to uncover mechanisms underlying
individual differences in dysmenorrhea. The expected impact of this research is to (1) suggest new avenues for
treating dysmenorrhea through modifying the vaginal microbiota or metabolites (e.g., using drugs, probiotics,
and/or behavioral interventions), (2) reveal vaginal microbiota and/or metabolites as biomarkers, and (3)
generate a rich resource with large microbial metagenomic sequencing, metabolomic profiling, and detailed
phenotype, hormonal, and behavioral data to study mechanisms of dysmenorrhea and menstrual health. In the
long term, this work has the potential to lead to additional dysmenorrhea treatment options with the ultimate
goals of reducing pain and improving women's quality of life.

Public health relevance
PROJECT NARRATIVE Dysmenorrhea (characterized by menstrual pain) affects up to 95% of reproductive-age women, disrupts their daily activities, and increases their risk for other chronic pain conditions. We propose to examine relationships among vaginal microbiome, inflammatory mediators, metabolome, sex hormones, and individual differences in dysmenorrhea symptoms. This study is expected to discover new evidence that could lead to expanded treatment options for the most common gynecological pain condition.